Antimicrobial dermal matrices to promote infection free wound closure in cutaneous wounds

Overview: This CRP project aims at enabling regulatory clearance/approval and accelerating
commercial availability of a self-assembly peptide-based matrix (G4Derm) for the management
of wounds. Wound care is currently an expensive, multistep, and often cyclic process in which
wounds are treated with sequential products to 1) remove pathogens with antibiotics, 2) promote
a healthy cellular environment through hydrogel application, and 3) close the wound with skin
substitutes. The proposed product, G4Derm, is capable of simultaneously removing drug-
resistant microbes through biophysical disruption of bacterial membranes, while promoting host
tissue regeneration without added antibiotics or biologics. G4Derm can be used in inpatient
and outpatient wound care clinics to heal patients infected with drug-resistant bacteria, and to
reduce the 100,000 amputations performed each year in the US due to chronic wounds.
Key words: tissue regeneration, infections, wound healing, biomaterials, antimicrobial
Areas of application: tissue regeneration and repair, wound healing, infections
Subtopic name: Biomedical (BM) Technologies
Intellectual Merit: This CRP proposal will allow for completion of the FDA 510(k)-enabling data
demonstrating safety and efficacy of G4Derm as an antimicrobial cell-scaffolding matrix that is
simultaneously toxic to antibiotic-resistant bacterial strains, while remaining conducive to tissue
regeneration. The product uses a charge-based mechanism to lyse bacterial membranes upon
contact and has a porous structure to promote cellular infiltration and cell attachment.
Broader Impact: This CRP funding would enable the regulatory clearance and product launch of
G4Derm, providing healthcare systems with a novel antimicrobial technology that can eliminate
even drug-resistant bacterial strains from infected wounds while simultaneously promoting wound
closure via tissue regeneration. According to the Centers for Disease Control and Prevention
Report, antibiotic-resistant bacteria will cause serious infections in 2 million Americans each year,
resulting in an estimated 23,000 deaths annually. Our ability to fight antibiotic-resistant bacteria
is diminishing, and the pipeline of new potential antibiotic drugs is growing lean. Only 9 new
antibiotics have received FDA approval since 1998, of which only 2 of these incorporated novel
mechanisms of action. Hence, the proposed product offers the unprecedented combination of
simultaneous pathogen elimination and host tissue regeneration. As the antibacterial mechanism
is biophysical, bacteria are unlikely to develop resistance to this product.

Public health relevance
Project Narrative Skin wounds affect millions of patients in the U.S. alone and its management presents a huge economic and healthcare burden. The proposed project described in this CRP application will lead to the realization of a new technological approach for wound management: a flowable, biodegradable synthetic wound matrix that synergistically combines the benefits of antimicrobial dressings, hydrogels, and skin substitutes into a single, easy to use product. G4Derm combines essential characteristics to promote infection free wound repair and regeneration: (i) flowability for full and intimate contact with the contours of wound-bed to fill wounds of any size, shape and depth, (ii) intrinsic broad spectrum antimicrobial activity to prevent and inhibit pathogen growth, (iii) high water content to maintain moist wound environment, and (iv) scaffolding matrix properties for wound closure and tissue regeneration. Adoption of this new technology is expected to reduce the frequency of surgical debridement in chronic wounds, breaking the cycle of infection recurrence in chronic wounds, expedite wound closure, reduce use of antibiotics, reduce nursing time, lessen patient pain, reduce length of hospital stays, and therefore significantly decrease overall wound treatment costs.